Standardization of Evaluation to Treatment of pediatric perianal Crohn’s disease and improving Outcomes through Networking (SETON)

ABSTRACT
Antibiotics are given universally to treat Crohn’s disease, especially with perianal fistulizing complications (PFC),
which occur in about 1/3 of children. Decreasing the utilization is challenging, yet significant, as many guidelines
support the use of antibiotics as first-line despite a lack of research showing benefit. Furthermore, there is such
variation in treatment not only regarding antibiotic use but also around use of other medications, interventions
such as drainage, and timing of each of these. In this innovative proposal, the investigators evaluate the current
practices for management of PFC in Crohn’s disease at seven large pediatric institutions, develop a protocol to
guide antibiotic stewardship, and improve care through a multidisciplinary approach (pediatric gastroenterology,
surgery, infectious disease, radiology, and nursing) and prospective implementation arm for data collection and
evaluation of barriers and facilitators. Our central hypothesis is that antibiotic use for PFC in Crohn’s disease
can be reduced, and outcomes improved through standardization of multidisciplinary care of children. The
rationale for this project is that reduction in antibiotic use and providing higher quality care will reduce the risk of
developing healthcare-associated infections such as clostridioides difficile, acquiring resistant organisms, and
improved care will also reduce the risk of perianal abscess development or fistula recurrence among pediatric
patients with Crohn’s disease. We will test our hypothesis through the specific aims: 1) describe variation in
antibiotic use and treatment of PFCs among pediatric patients with Crohn’s disease at seven children’s hospitals;
2) develop evidence-based protocols through multidisciplinary, multicenter collaboration aimed at antibiotic
reduction and standardization of PFC care; and 3) implement the protocols for antibiotic stewardship and
prospectively evaluate the barriers and facilitators with shared insight of best practices for pediatric Crohn’s
disease. This approach will create an evidence-base for antibiotic utilization while standardizing the care for
pediatric Crohn’s disease at several institutions with prospective evaluation of outcomes. The proposed research
is innovative because it brings together multidisciplinary teams from multiple institutions to develop a shared
approach to improving care, that is currently not standardized, or evidence-based. The proposed study is
significant because it has the potential to change the paradigm for pediatric multidisciplinary care of complex
conditions beyond pediatric Crohn’s disease.

Public health relevance
NARRATIVE Perianal fistulizing complications of Crohn’s disease are common and morbid, which are routinely treated with prolonged and frequent antibiotic courses, despite lack of evidence for efficacy. This proposed multicenter study is relevant to improving the appropriate use of antibiotics by promoting antibiotic stewardship and decreasing healthcare related infections, because it focuses on treating and preventing perianal fistulas and abscess through developing multi-disciplinary comprehensive evidence-based treatment guidelines for the judicious use of antibiotics while improving care for children with Crohn’s disease. Thus, the proposed research is relevant to the part of AHRQ’s mission to produce evidence to make health care safer and higher quality.